The association of placental gene expression and newborn metabolic profiles in understanding childhood asthma pathogenesis

PROJECT SUMMARY
Interactions between the genome and environment can be assessed through examination of metabolic profiles.
As the development of asthma is highly influenced by genetic and environmental factors, assessment of meta-
bolic profiles can improve our understanding of disease pathogenesis. We have demonstrated that select me-
tabolite concentrations at birth are associated with risk of early life wheezing and asthma. Further, we have
identified genetic pathways linking birth metabolic profiles with childhood asthma. While these findings shed
some light on biologic processes leading to asthma development, we do not understand intermediary pro-
cesses, such as gene expression within specific tissues, that may identify and allow targeting of disease-caus-
ing pathways. Placental changes have been shown to be associated with certain diseases in childhood. How-
ever, very little is known about the impact of placental changes in the development of childhood asthma. Given
the immunomodulatory and metabolic role of the placenta and its importance in mitigating adverse effects from
the environment, this organ is likely to play an important role in asthma susceptibility and resilience.
The overall objective of this proposal is to elucidate placental-specific transcriptomic pathways impacting the
metabolome and underlying childhood asthma pathogenesis. The rationale is that identifying relationships be-
tween placental-specific transcriptomic pathways, newborn metabolism, and childhood asthma will expand our
understanding of the fetal programming of asthma, highlight an asthma-relevant tissue, and identify target
genes for prioritization of future functional characterization. We will pursue the following specific aims: 1) deter-
mine associations between predicted gene expression in human placenta and early life wheezing and asthma-
related newborn metabolite concentrations, and 2) determine associations between placental predicted expres-
sion and early life wheezing and asthma and estimate the effect of placental predicted expression on childhood
asthma that is mediated through newborn metabolite concentrations. To achieve Aim 1, we will generate pla-
cental gene expression data from an ongoing pregnancy cohort and regress predicted expression on metabo-
lite concentrations using genotypes and targeted newborn metabolites from a prospective birth cohort. To
achieve Aim 2, we will utilize placental expression data outlined in Aim 1 and wheezing and asthma summary
statistics from large GWAS to determine associations between placental predicted gene expression and
wheezing and asthma. We will then perform a mediation analysis using findings from our previous work and
findings from Aims 1 and 2A to estimate the fraction of the effect of placental gene expression on childhood
asthma that is mediated by newborn metabolite concentrations. Potential impact: Successful completion of the
proposed research will provide important insights on the role of the placenta in the development of childhood
asthma and identify potential targets for prevention. As asthma is among the most prevalent chronic diseases
of childhood, development of effective prevention strategies could have enormous public health impact.

Public health relevance
PROJECT NARRATIVE Childhood asthma is a burdensome disease for which no effective prevention strategies currently exist; im- proved understanding of molecular processes underlying asthma development will significantly aid in our ability to target disease causing pathways. This study aims to elucidate placental-specific transcriptomic pathways impacting the metabolome and underlying childhood asthma pathogenesis. Successful completion of these a priori formulated research questions and the application of rigorous study designs and analyses will expand our understanding of the fetal programming of asthma, highlight an asthma-relevant tissue, and identify target genes for prioritization of future functional characterization.